Development of second-generation probiotics as radiation mitigators

The University of Pittsburgh and the University of Wisconsin have developed a Lactobacillus reuteri-based cytokine delivery platform (LRC-DP) to mitigate acute gastrointestinal radiation syndrome (GI-ARS) and has licensed this technology to ChromoLogic. ChromoLogic has developed a LRC-DP construct that produces the cytokines IL-22 or IFN-β and plans to test efficacy in animal models of GI-ARS.